Mechanisms of Immune Activation and Disease Progression in Animal Models

AGM STUDIES:
A crucial element in understanding the pathogenesis of lentiviral infections is to compare and contrast parameters between progressive and non-progressive infections. Indeed, elucidating the mechanisms underlying AIDS resistance of SIV-infected natural hosts may provide critical information to better understand AIDS pathogenesis. To date, >40 primate lentiviruses have been found to naturally infect African nonhuman primate hosts at high prevalence levels. In general, SIVs infecting African species evolved through host-dependent evolution, meaning that they have infected different NHP species for thousands, or hundreds of thousands, of years, possibly since primate speciation. During this long history, SIVs and their natural hosts evolved to coexistence, with the African NHPs infected with their species-specific viruses generally not showing signs of SIV-induced disease or simian AIDS. During this report period we have shown that CD4 expression is not required for most effector functions that these cells perform. We were also able to perform transcriptional and ATACseq analysis to understand mechanisms underlying CD4 down regulation. We have shown that epigenetic modification to the CD4 locus lead to CD4 down regulation in mature CD4 T cells.

MICROBIAL TRANSLOCATION STUDIES
Progressive lentiviral infection of primates is associated with a multifaceted activation of the immune system. This chronic immune activation has been shown to be tightly associated with HIV and SIV disease progression. We recently showed that one of the major causes of this chronic immune activation was microbial translocation. During the acute phase of infection the structural and immunological barrier of the gastrointestinal tract are damaged and microbial products consequently translocate from the lumen into peripheral circulation. In circulation these microbial products can stimulate the adaptive and innate arms of the immune system. Indeed, we found significant correlations between microbial translocation and measures of immune activation in chronically HIV/SIV-infected individuals. During this report period we have shown how ARVs change the composition of the GI tract microbiome and how inflammation leads to retention of tissue-resident SIV-specific CD8 T cells. We believe these data will lead to novel therapeutic interventions which improve the prognosis of HIV-infected individuals.